Genomic risk in clinic care to promote health equity in New York City patients

PROJECT SUMMARY
Building on our track record in genomic research, clinical trials, and genomic medicine in diverse, underserved
patients from NYC, we propose to develop new frameworks to bring genomic risk into clinical care to promote
health equity. Polygenic risk scores (PRS) are entering an exciting phase where they are poised to improve
health outcomes for myriad complex diseases through enhanced risk stratification and clinical decision making.
However, major challenges exist for clinical PRS implementation today. The vast majority of PRS have far
greater predictive value in individuals of European ancestry than other ancestries, and issues of access to
leading-edge genomic technology, research, and testing disproportionately impact underserved populations.
To address this, Mount Sinai experts in statistical genetics and population genetics, with decade-long
experience in building methods tailored to diverse and admixed populations, will work together to rigorously
develop multi-ethnic PRS. We will integrate multi-ethnic PRS with standard clinical risk and family history
information to generate genomic risk assessments for 15 common diseases. Drawing on Mount Sinai's century
of experience serving one of the most diverse patient populations in the world, we will recruit 2,500 adult and
pediatric patients from diverse and underserved populations into a clinical trial. We will estimate participants'
individualized risk for each condition, and investigate the impact of genomic risk communication to patients and
their physicians, including patient understanding and uptake of recommended risk-reducing interventions. We
will explore attitudes, barriers, and communication preferences related to genomic risk assessment in diverse
populations. Knowledge gained will be used to guide the development of a new multilingual patient-facing
digital platform supporting patient education and communication of genomic risk. We will track patient
engagement with their results through the platform, and assess the impact of individualized genomic risk
assessments on patient-reported psychosocial outcomes and experiences. As of today, the path to effectively
integrate genomic risk into clinical care in busy health systems, particularly for diverse patients, is unclear.
Hence, we are partnering with clinicians, scientists, industry experts, and community stakeholders to explore a
range of strategies to assess, communicate, and reduce disease risk, in order to maximize the efficiency of
genomic medicine delivery, and promote health equity.

Public health relevance
PROJECT NARRATIVE Major challenges exist for including genomic information broadly into clinical risk assessment in diverse and multi-ethnic populations, and issues of bias in research databases, community engagement, and access to leading-edge digital technology disproportionately impact underserved populations. We will recruit 2,500 ethnically diverse and medically underserved NYC patients into a clinical trial to estimate individualized disease risk and investigate the impact of genomic risk communication to patients and their physicians, including trust and understanding of the information, uptake of recommended interventions, and psychosocial outcomes. We will work closely with our NHGRI, eMERGE, community, industry, and health system partners, and use lessons learned to inform future research and clinical strategies, maximize efficiency for genomic medicine delivery, and promote health equity.